NIA Academic Career Leadership Award in Alzheimer's Disease

The present Academic Leadership Award (K07) application is to request support for Sanjay Asthana, MD to integrate the.remarkable resources of the University of Wisconsin (UW)-Madison, and develop a comprehensive, translational, interdisciplinary, and campus-wide research program in Alzheimer's disease (AD). The UW has a long and distinguished history of conducting cutting edge research in neuroscience; however, the university does not currently sponsor a dedicated program in AD research on its campus. Establishing a preeminent research program in AD is one of the top strategic priorities for UW. To that end, recent recruitment of Dr. Asthana from the University of Washington into a leadership position in gerontology, and commitment of substantial institutional resources has facilitated establishment of a preeminent AD research program at UW. It is anticipated that this program will form the basis for a NIA- funded Alzheimer's Disease Research Center (ADRC) at UW. The major objectives of the proposed AD research Program include the following: 1. To bring together extensive resources and infrastructure of UW toward developing a campus-wide, interdisciplinary, and translational research program in AD. 2. To develop various "research cores" necessary to establish a NIH-funded Alzheimer's Disease Research Center (ADRC) at UW. 3. To develop a comprehensive training program related to the neurobiology, diagnosis, and treatment of AD. 4. To enhance the interest and attract some of the current UW neuroscience faculty members into AD research.